Administrative Supplement for Enhancement of Software Tools for Open Science through CHILDES

This project seeks to restructure the software system supporting the CHILDES (Child Language Data Exchange System) Project. CHILDES provides data in the form of transcripts and linked media for the study of child language development. This supplement to the CHILDES grant will leverage best practices in software development and advances in cloud computing to improve the impact, reliability, sustainability, scalability, and openness of the CHILDES Project tools and database. The project will support the modernization and containerization of CHILDES software.

Public health relevance
This project seeks to restructure the entire software system supporting the CHILDES Project. It will leverage best practices in software development and advances in cloud computing to improve the impact, reliability, sustainability, scalability, and openness of the CHILDES Project tools, database, and community in accord with FAIR principles. This will be done by converting the current XML-based data model to JSON, modularization and containerization of all software components, and integration of the containers through the Kubernetes orchestration system. These improvements will open the system to community open-source development of current and software components, thereby vastly widening the scope of empirical issues that can be addressed from the database.